THE NITRIC OXIDE PATHWAY--THE ROLE OF NITRIC OXIDE IN SEPTIC SHOCK

Endothelial cell derived relaxing factor has been identified to be nitric oxide and the pathway responsible for its synthesis in human cells has been elucidated. Further, antagonists of this pathway have been synthesized and shown to block the hypotension caused by tumor necrosis factor, an important mediator of septic shock. In these investigations, the nitric oxide pathway is being examined in patients with septic shock an in normal volunteers given endotoxin. We are looking for evidence of nitric oxide synthase induction during the systemic inflammatory response to clarify the role of this pathway in human disease. The initial phase of this project has begun in normal volunteers given either sodium nitroprusside or endotoxin (Abstract, American Thoracic Society, 1995). Methods have been developed to measure exhaled nitric oxide, serum and urine nitrite/nitrate concentrations and cGMP in addition to standard cardiovascular and pulmonary physiology. We found that sodium nitroprusside produced a fall in mean arterial pressure (MAP) and measurable increases in exhaled nitric oxide and urinary nitrite/nitrate and cGMP. In contrast, endotoxin produced a fall in MAP, but no measurable changes in the activity the nitric oxide pathway. Future studies will examine induction of nitric oxide production in the lung after intrabronchial administration of endotoxin. These latter experiments are being conducted in conjunction with in vitro studies examining the role of nitric oxide in modulating the interaction between human neutrophils and bronchial epithelial cells (Z0I-CL-0I 14-03-CCMD).